Coordinating Center for Research and Training to Promote the Health of People wit

DESCRIPTION (provided by applicant): Disability and public health remain an elusive combination despite obvious synergies. Birth defects, developmental and other disabilities, health and care disparities in disability, and health and wellness for people with disabilities are not commonly noted in medical and health education and service programs. This proposal is designed to develop a Center to focus a program of activities in support of the initiative and mandates of the NCBDDD, called the Disability Research and Dissemination Center (DRDC). DRDC will require a collaborative that includes prominent organizations, networks, and groups with the capacity to carry out public health research, training, and practice in the areas of birth defects, developmental and other disabilities; avoid health disparities for people with disabilitie of all ages; and promote health and development of persons with disabilities across the lifespan. DRDC will be organized through 5 Cores: 1) Administration to provide infrastructure and coordination for Center activities; 2) Research to support NCBDD priorities and those of the Center; 3) Training and Evidence-Based Programs to catalogue/promote evidence-based practices for wellness and develop professionals' education; 4) Dissemination to advance information with and for stakeholders and others; 5) Evaluation to assess processes of the Center and assure research and product integrity. The collaborative will bring together nationally prominent disability experts in pediatrics, rehabilitation medicine, preventive medicine and public health, behavioral health, genetics, epidemiology and biostatistics, health promotion, nursing, social work and related fields who are located within universities, schools of public health and medical schools throughout the US. The organizational framework allows us to be inclusive of medical and health education programs and tenure track faculty in university settings, plus colleagues in public and private organizations and businesses, who have expertise in research and training to promote the health of people with developmental and other disabilities. Our primary team and Cores will be housed at University of South Carolina (Columbia, SC), SUNY Upstate Medical University (Syracuse, NY), and American Association on Health and Disability (Washington, DC). The primary team has successfully worked together to establish and expand the field specific journal, Disability and Health Journal.

Public health relevance
Project Narrative This project is designed to identify and fund the best research in this field, foster training of public health and other professionals, and to use the most progressive mechanisms to disseminate knowledge about evidenced-based practice. The ultimate goal of the Disability Research and Dissemination Center (DRDC) is to increase scientific and public awareness about areas related to developmental and other disabilities, with a promise of scientific breakthroughs, new policies, and new areas of research which will positively impact the health of persons across the lifespan living with birth defects and disabilities. __SpecificAimsTextDelimiter__ 1. Specific Aims The overall aim of this cooperative agreement is to expand NCBDDD's capacity to conduct research and training, and to disseminate evidence-based practice related to birth defects and developmental and other disabilities by establishing a Disability Research and Dissemination Center (DRDC). Aim 1: Establish a national DRDC that builds on the foundation of two national universities (University of South Carolina [USC] and State University of New York Upstate Medical University [SUNY-Upstate]) and a national dissemination and policy organization (American Association for Health and Disability [AAHD]). • Target 1a: Develop an Administrative Core for centralized management and oversight • Target 1b: Establish an advisory board, the External Advisory Council (EAC) • Target 1c: Establish partnerships (External Partners) for solicitation/dissemination Aim 2: Conduct research related to NCBDDD priorities using a network of University partners that includes medical, social and basic science, and public health approaches. • Target 2a: Conduct research related to conditions and methods described in the RFA • Target 2b: Develop a method to determine research priorities, and prioritize annually • Target 2c: Solicit and review proposals and make awards Aim 3: Advance evidence-based programs and practices that promote the health and well- being of people with disabilities of all ages and their families. • Target 3a: Develop a search/evaluation strategy, catalogue/maintain evidence-based programs • Target 3b: Develop and/or disseminate promising practices that are supported by research Aim 4: Train health and public health professionals. • Target 4a: Develop DRDC-NCBDDD Collaborative Fellowship Awards • Target 4b: Conduct Learners' Needs Analysis • Target 4c: Identify, catalog, and maintain a collection of professionals' education materials • Target 4d: Develop and/or promote promising teaching materials to medical/public health school Aim 5: Communicate and disseminate intervention and other information with and for stakeholders and other audiences • Target 5a: Establish and maintain a DRDC web and social media strategy • Target 5b: Organize the Stakeholders' Network • Target 5c: Convene meetings of stakeholders to discuss/address research, policy, program issues • Target 5d: Provide technical assistance • Target 5e: Support implementation of evidence-based health promotion activities • Target 5f: Collect/distribute policy and legislation involving those with/at risk for disabilities Aim 6: Evaluate and report on processes of the Center and assure research & product integrity • Target 6a: Conduct a needs assessment to set DRDC agenda and formalize the evaluation process • Target 6b: Implement ongoing evaluation of processes, research, products, and other activities These aims will be achieved through the collaboration of three primary partners/sites and national organizations that have a broad reach that far exceeds the organized networks presently active in disability research. Hundreds of experts throughout the U.S. are conducting research on aspects of birth defects and disabilities. This proposal is designed to identify and fund the best research in this field, foster training of public health and other professionals, and to use the most progressive mechanisms to disseminate knowledge about evidence-based practice. The University of South Carolina School of Medicine will be the administrative home of the DRDC. The sites at SUNY-Upstate and AAHD will broaden the reach of the DRDC. The record of the three PIs, who have worked together for five years as Co-Editors and sponsoring organization for Disability and Health Journal (DHJO), provides evidence that collaborations using modern technology eliminate the need for physical proximity. DRDC will address the above aims and specific, measureable, attainable, relevant, timely (SMART) targets of the DRDC, monitored by the Evaluation Core.